Development and Assessment of Nicotine Continuum of Risk Education on Tobacco Use Among Socioeconomically Disadvantaged Adults

PROJECT SUMMARY
Adults who are socioeconomically disadvantaged (“Low-SES”) are at increased risk of heavy smoking, face
reduced cessation success, and bear a disproportionate burden of smoking-attributable morbidity and
mortality. Encouraging smokers who are not able or ready to quit smoking to switch to lower harm non-
combustible products could reduce this burden. However, the success of these efforts relies upon smokers
understanding that the health risks of nicotine-containing products are not identical but lie along a continuum,
with combustible products being the most harmful and noncombustible products being significantly less
harmful. Studies have identified a general lack of knowledge about the relative risks of nicotine-containing
products across the population, and evidence suggests that low-SES adults may be less knowledgeable than
higher-SES adults about the continuum of risk (COR). There is still a lack of evidence about COR perceptions
among low-SES smokers, the effectiveness of educational messages designed to boost COR knowledge, and
whether increasing COR knowledge increases intentions to switch products and reduces combustible product
use. This proposal aims to 1) use qualitative methods to assess COR perceptions among low-SES smokers, 2)
design and test candidate COR educational messages, and 3) investigate the effects of exposure to COR
educational messages on COR knowledge, intentions to switch from combustible to noncombustible products,
and reductions in combustible product use among low-SES smokers. A comprehensive training plan will
ensure successful execution of these aims, with four overall goals for the PI during the training period: 1)
proficiency in qualitative research methodology, 2) acquire expertise in clinical trial administration, leadership,
and methodology, 3) acquire expertise in advanced statistical methods to evaluate the effects of interventions,
and 4) develop expertise in designing, optimizing, and testing health communications. Training will be guided
by a team of expert mentors with complementary areas of expertise and current, strong collaborative
relationships with one another. The research and associated training will also be supported by the strong
training environment at Virginia Commonwealth University. This K01 will prepare the PI to successfully lead
future independent studies focused on reducing the burden of tobacco and other substance use among
vulnerable populations.

Public health relevance
PROJECT NARRATIVE This proposal aims to develop and assess the effects of exposure to novel educational messages focused on correcting misperceptions about the continuum of health risks for nicotine delivered in combustible versus non- combustible products, specifically among socioeconomically disadvantaged adults who smoke cigarettes. Increasing continuum of risk knowledge among smokers at disparate risk for heavy smoking and resulting health consequences is timely and relevant to public health priorities in the field of tobacco regulatory science and will inform future research regarding use of public education to reduce the health consequences of smoking.